Developing a low cost, highly compact holographic imaging based microfluidic cell sorting system using 3D printing

SUMMARY
With advancement in machine vision and deep learning, imaging-based microfluidics have demonstrated their
potential to serve as precise single cell analysis and sorting devices for various challenging medical applications
including bioprinting and cell patterning, sorting rare cells (e.g., circulating tumor cells, sickle cells) from blood
for disease (e.g., cancer, sickle diseases) diagnosis, etc. However, current imaging-based microfluidic cell
sorting systems suffer from the issues of low throughput and world-to-chip interfacing. These issues are largely
related to the shallow depth of field of conventional microscopic imaging, which significantly restricts the number
of cells that can be analyzed per image and increases the complexity and cost involved in fabricating cell sorting
chips integrated with imaging and valve actuation capabilities. These issues limit the implementation of such
microfluidic systems in clinical diagnostics and treatment, particularly in which target cells are extremely rare in
samples. Although different types of high throughput cell sorting microfluidic systems have been developed, they
either have insufficient sorting precision or require the integration of different sorting methods, which further
increases the system complexity and lowers its reliability.
This exploratory R21 project aims to develop a high throughput, low cost and compact solution for imaging-
based cell sorting microfluidic devices to improve their appeal for critical clinical applications. Our solution utilizes
3D holographic imaging to overcome the depth of field issue of conventional microscopic imaging, increase the
specificity of cell detection, and enables high throughput and high precision cell sorting using microfluidics. We
will use multi-material 3D printing technique to generate fast responsive sorting valves and miniaturized
holographic imaging sensors with performance that exceeds the ones in the literature. Our approach will not
only substantially reduce the cost, time, and enhance the degree of automation for fabricating these microfluidic
devices, but also enable sleek and compact microfluidic design, contamination-free fabrication, and superior and
consistent imaging quality during hours of operation that is essential for many clinical operations. The 3D printing
approach developed in this project can provide the basis for low cost and high efficiency fabrication of a broad
range of microfluidic devices used in medical research and clinical applications (e.g., lab-on-a-chip diagnostics,
point-of-care systems, organ replication-on-a-chip, and bioassays). The integration of 3D imaging capability with
3D printing will enable new designs of high throughput, high precision, and high specificity microfluidic systems
with versatile functionalities that are not available in conventional microfluidics used in medical field. In particular,
the cell sorting devices fabricated in this proposed project can significantly speed up the cell-based liquid biopsy
for cancer diagnostics and personalized cancer treatment.

Public health relevance
NARRATIVE The proposed research is relevant to public health because it will improve our ability to use liquid biopsy for early and nonintrusive disease diagnostics. This technology is driving the push towards early cancer diagnostics and personalized cancer treatment. The proposed research is relevant to the mission of the NHGRI to develop and improve novel technologies for fundamental medical research and clinical applications (e.g., liquid biopsy).